A Feeding Dynamic Intervention for Regulation of Energy Intake

DESCRIPTION (provided by applicant): In the last three decade, there has been a marked increase in the prevalence of childhood obesity. Currently, 23% of preschoolers (2-5 years) in the United States are overweight or obese, a critical period to target in hopes of reversing this trend. Emerging consensus indicates that excessive, intrusive, overt control in feeding or a chaotic non-structured feeding environment are risk factors for childhood obesity. Targeting these behaviors has significant potential for obesity treatment. In this 3-year R03 application, we propose to investigate the efficacy of a Feeding Dynamic Intervention (FDI) for improving caregiver feeding practices, child eating behaviors, and child self-regulation of energy intake in the short term. In a pilot randomized controlled trial of 84 mothers with 3- to 5-year-old obese children, we will examine the effect of our FDI in comparison to a wait-list control group (WLG) on (i) maternal self-reported feeding practices;(ii) improving energy compensation (COMPX), decreasing Eating in the Absence of Hunger (EAH) and increasing mother-reported satiety responsiveness in their child. Finally, we will investigate an exploratory hypothesis that children in the FDI group, compared to children in the wait-list control group, will demonstrate a lower increase in body mass index (BMI) z-score over 6 months. At the completion of this study, we expect to know: (1) the effect of the FDI on maternal self- reported feeding practices for obese children;(2) the degree to which children can be taught to self-regulate their food intake via parent-directed intervention;and (3) the estimated effect size to enable us to calculate sample size requirements for a subsequent large-scale multicenter trial in an R01 application. Our long-term research goal is to develop effective and pragmatic interventions that enable children to improve their self-regulation of energy intake and maintain a healthy weight. PUBLIC HEALTH RELEVANCE: The proposed research will test an innovative approach to augment limited existing interventions for obese preschoolers and advance our understanding of self-regulation of energy intake among young children.

Public health relevance
The proposed research will test an innovative approach to augment limited existing interventions for obese preschoolers and advance our understanding of self-regulation of energy intake among young children.